Defining the Roles of Bone Marrow Adipocytes and FABP4/5 Signaling in Multiple Myeloma Drug Resistance

Cancer develops and spreads because of the nature of the tumor and the microenvironment or `soil' in which
the tumor is embedded. Multiple myeloma is a blood cancer that results from mutations that accumulate in a
plasma cell. Multiple myeloma cells grow in the rich soil of the bone marrow, first very slowly, causing no
damage or symptoms, and then more quickly and aggressively, causing degradation of the bone and
development of drug resistant clones. The risk of developing myeloma is greater in older individuals and
people with high body mass index. These patients also typically have more bone marrow adipose tissue, or fat,
than younger or leaner individuals. However, the ways in which bone marrow adipocytes (fat cells) modulate
disease progression are not well understood. Thus, we aim to identify new therapeutic avenues to halt multiple
myeloma progression by targeting the interactions between myeloma cells and bone marrow adipocytes to
lead to better therapeutics for patients. Due to the potentially inflammatory nature of bone marrow adipose
tissue, and its ability to act as a source of fatty acids and adipokines, we wanted to explore how bone marrow
adipose tissue affects myeloma tumor cells. Our cell culture studies suggest bone marrow adipocytes induce
drug resistance in myeloma cells through proteins called fatty acid-binding proteins 4 and 5 (FABP4 and
FABP5). In Specific Aim 1 of this proposal, we will analyze how bone marrow adipocytes contribute to
myeloma by using novel, three-dimensional (3D), tissue engineered cancer models. Compared to two-
dimensional (2D) cultures, 3D cultures much more realistically recapitulate what happens in the human body.
The tissue engineered models are made from silk scaffolds, bone marrow adipocytes, and cancer cells. By
growing myeloma cells in these 3D mini-bone environments, we can determine how myeloma cells change in
response to adipocytes and discover new ways to target this interaction. In Specific Aim 2 of our proposal, we
will use mouse models to study bone marrow adipocyte and myeloma crosstalk. Our mouse models
recapitulate very closely how tumors grow in patients. We will test how increasing or removing bone marrow
adipocytes in mice affects tumor growth and drug resistance, and we will test specifically the role of FABP4
and FABP5 in this process. We will use these in vitro and in vivo models, which we have already developed
and optimized in our lab, to better understand how cancer hijacks the bone marrow niche for its own purposes.
Our long-term goal is to understand molecules and mechanisms driving multiple myeloma growth in the bone
marrow. This proposal feeds into that by interrogating a novel part of the cellular “soil” (the bone marrow
adipocyte), in which tumor cells, or “seeds” land and grow. In sum, our research will identify feedback loops
between host and cancer cells, indicate mediators of this interaction, and propose paradigm-shifting concepts
to guide the development of new anti-myeloma therapies.

Public health relevance
The overall goal of this application is to change how multiple myeloma, an incurable blood cancer, is understood and treated. We will discover new forms of cancer drug resistance that are driven by fat cell- derived factors. Thus, we will expose new interventions to overcome drug resistance to improve survival and quality of life for myeloma patients and patients with other cancers that grow in the bone.